Dysregulated Oxalate Metabolism in Cardiometabolic Diseases

PROJECT SUMMARY/ABSTRACT
Affecting one third of the global population, with no pharmacotherapy available, nonalcoholic fatty liver disease
(NAFLD) has become the leading cause of chronic liver disease. Surprisingly, the major cause of death in
patients with NAFLD and the more severe nonalcoholic steatohepatitis (NASH) is atherosclerotic cardiovascular
disease (CVD). This highlights a critical need to identify targetable pathways for concurrent treatment, which has
been hampered by limited understanding of the pathophysiology and metabolic pathways linking these two
diseases. Recently, we and others uncovered oxalate metabolism commonly dysregulated in NAFLD and CVD.
While oxalate effects in the kidneys are well known, they have not been systematically studied in hepatocytes,
the primary cells responsible for its formation. Moreover, in NASH and associated atherosclerosis, a causative
role of oxalate, its underlying mechanisms and the therapeutic potential of targeting oxalate overproduction are
unknown. Using unbiased transcriptomics, we uncovered suppression of genes that limit oxalate production in
livers from humans and mice with NASH. Alanine-glyoxylate aminotransferase (AGXT), a liver-specific enzyme
that detoxifies glyoxylate, the oxalate precursor, was reduced and oxalate was markedly increased in correlation
with NASH severity. Remarkably, oxalate was also increased both in patients and mice with atherosclerosis. In
our mouse model of hepatic oxalate overproduction (Agxt-/-), both NASH and atherosclerosis were increased
with suppressed hepatic fatty acid β-oxidation (FAO) and induced proinflammatory pathways. Atherosclerosis
was enhanced also by exogenous oxalate. In hepatocytes, oxalate induced mitochondrial dysfunction and lipid
accumulation while downregulating peroxisome proliferator-activated receptor α (PPARα) targets and
upregulating C-C motif chemokine ligand 5 (CCL5). Importantly, limiting oxalate production via liver-specific
AGXT overexpression, as proof-of-concept, attenuated NASH and atherosclerosis, underscoring the potential of
oxalate reduction for concurrent treatment. This project will address the central hypothesis that hepatic oxalate
overproduction drives NASH and atherosclerosis via mitochondrial dysfunction, impaired PPARα/FAO, and
CCL5 induction, while suppression of oxalate formation reduces established NASH and atherosclerosis. Aim 1
will determine the mechanisms by which oxalate drives NASH and associated atherosclerosis using novel mice
with hepatic oxalate overproduction, PPARα and CCL5 deficiency, combined with dietary and pharmacological
manipulation of oxalate, mitochondrial function and PPARα, and in vitro models. Aim 2 will define oxalate
reduction as a potential therapy for NASH and associated atherosclerosis using genetic and dietary approaches
to limit hepatic oxalate formation and enhance glyoxylate detoxification in vivo and in vitro. Aim 3 will characterize
hepatic oxalate overproduction and its genetic regulation in human NASH and atherosclerosis using epigenetics,
GWAS and human liver samples. This work will delineate a newly identified metabolic pathway linking NASH
and atherosclerosis and advance translation of oxalate reduction as a concurrent treatment for these diseases.

Public health relevance
PROJECT NARRATIVE The link between non-alcoholic fatty liver disease (NAFLD), affecting one third of the world population, and aggravated atherosclerotic cardiovascular disease, the major cause of death in patients with NAFLD, is poorly understood, hindering the development of effective therapies for simultaneous targeting. We uncovered that oxalate overproduction in the fatty liver concurrently fuels further progress of NAFLD and aggravation of atherosclerosis. We will address the molecular and metabolic mechanisms behind oxalate acting as a link between both diseases and provide evidence for the effectiveness of targeted therapies aimed at reducing oxalate, with the ultimate objective of accelerating translation of our findings into concurrent treatment of these two prominent diseases.